Colorado HNC SPORE Administrative Core

SUMMARY, Administrative Core
The goal of the Administrative Core of the Colorado Head and Neck Cancer (HNC) SPORE is to facilitate
innovative translational science that will accelerate the application of new discoveries to the clinic for HNC
patients. The primary objective of the Administrative Core is to provide scientific leadership, administrative
services and financial oversight, and to function as a communication hub for all SPORE-related activities. The
Administrative Core will support investigators and personnel in projects 1-3, the Biospecimen/Pathology Core,
the Developmental Research Program (DRP), the Career Enhancement Program (CEP), and the Tissue Use
Committee. The Administrative Core personnel interact with the patient advocates to coordinate their activities
and integrate their participation in SPORE activities and provides support to the External and Internal Advisory
Boards as well as visiting scientists, fellows, and all collaborating investigators from academia and industry. The
Administrative Core provides each of these groups with centralized organization and support for their activities,
and helps each group stay informed about activities, meetings, opportunities and other information pertinent to
the SPORE. The Administrative Core will be responsible for communication with NCI and will provide support
for all collaborations. Continuity of support provided by the staff will result in efficient and effective administration
for the CO HNC SPORE.

Public health relevance
NARRATIVE, Administrative Core The Administrative Core of the Colorado Head and Neck Cancer (HNC) SPORE will provide the operational administration to ensure the success of our SPORE as a whole. The benchmark of our success is to translate innovative research into clinical interventions for HNC patients.